Defining a Stromal Signature that Facilitates Progression of Lethal Cancers

Project Summary/Abstract
The activity proposed in this Research Specialist Award application is in line with the long-standing goals of Dr.
Thea Tlsty (the Unit Director)'s currently NCI-funded research program which currently supports my
activity/effort: i) understand dynamic mechanisms underlying cellular plasticity and tissue response to stress;
and ii) explore the role of tissue microenvironment and how these multiple factors contribute to tumor initiation
and progression. These efforts are particularly worthwhile when dealing with the most lethal type of breast
cancer, metaplastic breast cancers (MBCs). Identifying tissue components and signaling pathways that
contribute to the emergence of these cancers in order to design more successful therapies for patients
diagnosed with MBCs is indeed of the outmost clinical relevance. This application is the result of my personal
‘twist’ on the long-term interest of the Tlsty laboratory on the role of stromal-epithelial interactions in breast
tumorigenesis. Its core concept relies on the increasingly appreciated notion that cancer progression requires
an instructive tumor microenvironment (TME). Generation of a TME results from: acquisition of a cancer-
associated ﬁbroblast signature, a shift in macrophage type, alterations of ECM characteristics that either
facilitate or counteract tumor growth, a corrupted immune response, an expanded and leaky vasculature and
as a correlate an hypoxic environment and increased epithelial cell plasticity. Such phenotypes are exemplified
in aggressive tumors characterized by a desmoplastic stroma with extensive and altered ECM deposition
typified by MBCs. Thus, the imbalance in ECM composition seen in MBCs is the result of extensive structural
and functional stromal changes that result from alterations in both stromal and epithelial cell properties. Our
provocative prediction that a specific ECM/stromal make-up may identify cancers with the poorest outcome
across breast cancer subtypes (luminal, Her2-positive, basal-like) may be of high clinical relevance not only for
MBCs and basal-like cancers, but also for luminal breast cancers with late recurrence. To gain valuable
insights, I will: i) identify stromal drivers (and repressors) of progression of MBCs through comparative
proteomic analysis of ECM from breast tumor (including MBC) and disease-free breast specimens with an
emphasis on post-translational modification status; ii) interrogate gene expression databases for upregulation
(or down-regulation) of these ECM proteins across breast cancer subtypes (luminal, Her2-positive, basal,
claudin low) through data mining; iii) test the ability of some of these ECM proteins to drive (or repress) cell
plasticity (multilineage commitment and epithelial mesenchymal transition) in vitro using 3D cell culture models;
and iv) confirm in vivo the pro- (or anti-)metaplastic/tumorigenic activity of these ECM proteins in murine
xenograft models. My extensive experience in protein biochemistry, cell biology and characterization of mouse
models combined with my recent interest in data mining and multiplex immunohistochemistry, place me in an
optimal position for the novel pursuit of ECM alterations underlying progression of MBCs.

Public health relevance
Project Narrative My proposed activity is articulated around the concept that stromal tissue components play a key role in tumorigenesis and that combining therapeutic regimens aimed at normalizing the stroma with current malignant epithelium-centered therapies will minimize risk of relapse due to drug resistance. I will focus on identifying key extracellular matrix drivers of progression for a rare but lethal type of cancer, metaplastic carcinomas, for which there is no known therapy. I am well poised to carry out successfully the benchmarks I have delineated to reach the proposed goals owing to my background as biochemist, cell biologist and veterinarian combined with my many-fold involvement both at the scientific and programmatic levels in successful multidisciplinary and highly translational projects.